Cell-biological mechanisms underlying activity dependent Abeta generation

PROJECT 3: KOO/ROY - ABSTRACT The amyloid precursor protein (APP) is sequentially cleaved by β- and γ-secretases to generate amyloid β-peptide (Aβ) in the brain - a central player in the amyloid cascade hypothesis. APP cleavage by β-secretase-1 (BACE-1) is the rate-limiting step for production of Aβ. Aβ is believed to exert its toxicity on neurons while in a soluble and oligomeric state, prior to deposition as insoluble fibrils in brain. Thus, for reasons related to both pathophysiology and therapeutics, understanding mechanisms and pathways of Aβ generation from APP is a major focus of many laboratories. An intriguing aspect of Aβ production is that its release is dependent upon neuronal activity - enhanced synaptic activity results in more Aβ release. Though pathways involved in trafficking and cleavage of APP in neurons are of obvious importance, the vast majority of previous studies on APP/BACE-1 trafficking have been carried out in non-neuronal cells. These findings may not always be applicable to neurons, which are highly polarized and are known to have very different trafficking mechanisms. Furthermore, inferences on how neuronal activity modulates APP processing by BACE-1 require work in neurons. The prevailing view is that at presynaptic terminals, heightened synaptic vesicle recycling that accompanies high synaptic activity results in increased internalization into endosomes of APP where proteolysis by secretases take place. However, our recent studies using live neuronal imaging showed rather surprising results in that APP and BACE-1 normally traffic in distinct vesicles - perhaps preventing unabated cleavage - but converge in dendrites upon activity-induction. This led us to propose a new model whereby neuronal activity brings together APP and BACE-1 in dendrites where the two molecules interact. Only subsequently are these two molecules sorted into axons to distal terminals. Accordingly, this Project will examine a number of predictions that emanate from this working model and will allow us to refine the trafficking pathways of APP and BACE-1 and define how they relate to amyloidogenesis in neurons in an activity-dependent manner. Four Aims are proposed: 1) test the hypothesis that APP and BACE-1 are first sorted to dendrites immediately after biosynthesis, 2) determine the subcellular sites where APP and BACE-1 interact and correlate this to sites of Aβ release, 3) test the hypothesis that APP and BACE-1 are transcytosed from dendrites to axons, possibly in an activity dependent manner, and 4) utilize tissue from the Neuro-pathology Core to assess whether the colocalization of APP and BACE-1 is preferential to the default mode network brain regions which are known to be sites of Aβ deposits. Collectively, results from these studies will provide new insights into the trafficking pathways of APP and BACE-1 and demonstrate how neuronal activity modulates these pathways to enhance APP cleavage and Aβ release.

Public health relevance
PROJECT 3: KOO/ROY-PROJECT NARRATIVE This proposal explores the mechanisms by which neuronal activity elevates the production and subsequent release of amyloid β-protein (Aβ) from neurons, a phenomenon that may explain the preferential deposition of amyloid in brain regions that are part of the "default mode network". Our studies will test a new working model of how trafficking of the amyloid precursor protein (APP) is modulated during periods of high synaptic activity, thereby resulting in cleavage and subsequent release of Aβ peptides from neurons. Results from our study will lead to greater understanding of the mechanisms of Aβ production in neurons and why amyloid deposits are found in certain parts of the brain in individuals with AD.